2019 American Urological Association (AUA) Early-Career Investigators Workshop

2019 AUA EARLY-CAREER INVESTIGATORS WORKSHOP PROJECT SUMMARY/ABSTRACT The 2019 American Urological Association (AUA) Early-Career Investigators Workshop (ECIW) will be held October 3-5 at AUA Headquarters in Linthicum, Maryland, near BWI Airport. The workshop will provide intense, individualized instruction for a group of 35 early-career investigators and late-stage trainees on how to prepare innovative and competitive research grant applications, primarily to the NIH with emphasis on grants in benign urology. The program specifically provides one-on-one and small-group instruction by NIH-funded senior scientists and advisors. This advising is customized to best fit the needs of the individual applicants and the range of their proposed research applications. This workshop serves as a catalyst to increase the quality of urologic research grant proposals submitted to the NIH, and continues the long-range strategic vision of the AUA to provide a series of workshops that are devoted to successful grant writing, strengthening of scientific careers, and developing an integrated community of urologic investigators to support interdisciplinary research. The Principal Investigator (PI), Carolyn J.M. Best, PhD, is AUA Director of Research. The Steering Committee consists of urologic research leaders, some of whom are PIs on NIDDK Multidisciplinary K12 Urologic Research (KURe) Career Development Programs: Aria Olumi, MD (Chair); Rosalyn Adam, PhD; Cindy Amundsen, MD; Linda Baker, MD; Wade Bushman, MD, PhD; Toby Chai, MD; Peter Clark, MD; Margot Damaser, PhD; Stephen Freedland, MD; Michael Hsieh, MD, PhD; Dolores Lamb, PhD; John Wei, MD; and Erika Wolff, PhD. All faculty possess exemplary records in NIH research funding and mentoring trainees. During the 2½-day ECIW, faculty advisors will meet with participants to conduct evaluations of their grant applications. Advisors are matched to participants based on scientific area, to customize feedback on specific aims and methodologies of the proposed research. The program includes talks on key facets of grant writing, including, “Tech/Software Tools for Grant Writing,” “Identifying & Composing the Pieces of a Successful Research Grant Proposal,” “Selling Yourself Through Your NIH Biosketch,” “Establishing Effective Career Development Goals and Translation to Your Training Plan,” and a “Specific Aims Writing Workshop.” Presentations on negotiations, collaboration, project management, mentoring, and career development from successful senior and mid-career investigators will also be provided. Advisors with experience on NIH study sections conduct mock critiques on previously NIH-reviewed grant applications during a Mock Review Panel.

Public health relevance
2019 AUA EARLY-CAREER INVESTIGATORS WORKSHOP PROJECT NARRATIVE/ PUBLIC HEALTH RELEVANCE STATEMENT This application seeks support to enable the American Urological Association (AUA) to invite early-career investigators (and late-stage trainees) to participate in a proven, impactful workshop (AUA Early-Career Investigators Workshop, October 3-5, 2019) that provides an intensive grant writing curriculum, in-depth evaluation of grant applications in preparation for submission, instruction from senior scientific advisors in one- on-one and small group settings, and instruction in other essential elements of a successful research career. This workshop is part of a major effort by the AUA to develop an enduring urology-wide program devoted to improving the number and quality of urology research grant applications submitted to the NIH, which has identified a critical deficiency in the pipeline of surgeon-scientists and other urology investigators. Without intervention by the AUA in the attrition from research of urology surgeon-scientists and the basic science researchers that can participate in urology team science, the development of improvements in urology patient diagnosis, treatment, and hopefully cures, will be further stalled, if not eliminated, at a time when the number of patients with urologic diseases and conditions is rapidly growing.